Controlled Release Eczema Bandage (CREB)

Project Summary/Abstract:
CFD Research Corporation has developed a novel microbiome-balancing wet wrap therapy for atopic
dermatitis based on a natural compound with unique physicochemical and pharmacological activities. The
compound has been found to have an interleukin-based immune modulatory effect that helps soothe the flare-
up of eczema, and it is highly selective to the pathogen Staphylococcus aureus while being gentle to the skin
microbiome, including beneficial bacteria such as Roseomonas mucosa and Corynebacterium
tuberculostearicum.
The compound was incorporated into cellulose-based fabrics such as rayon and cotton to create a
controlled-release wet wrap/bandage which will be tested on mouse models of eczema. The technology has the
potential become a standard of care for treating eczema patients and decrease or eliminate the use of steroid
ointments in controlling atopic dermatitis in children and adult populations.

Public health relevance
Project Narrative: This project aims to develop controlled-release skin microbiome-balancing antimicrobial cotton fabrics to use as bandages in the treatment of atopic dermatitis and eczema infections.